Neural Basis of Human Working Memory

PROJECT SUMMARY
Working memory, the ability to maintain information in mind over a period of seconds, is compromised in several
mental illnesses and neurological conditions, including schizophrenia. The prefrontal cortex has been thought of
as the primary site of working memory maintenance, though conflicting results have been obtained from human
imaging and animal neurophysiological studies. To resolve this question, we will obtain neurophysiological
recordings from human patients implanted with intracranial electrodes prior to epilepsy surgery and isolate
spiking activity and local field potentials. The patients will perform working memory tasks closely modeled after
tasks used in the non-human primate neurophysiological literature, requiring maintenance in memory of visual
spatial, and shape information. We will thus be able to address the neural basis of memory at the level of neuronal
firing in the human prefrontal cortex and other cortical areas, and compare our findings with the large literature
of similar studies in non-human primate animal models. Specifically, we will address whether neuronal spiking
in the prefrontal cortex exhibits selectivity for spatial locations objects held in memory or plays a more general
supervisory or control role. Further, we will test predictions of competing models of working memory by using
electrical stimulation to perturb neural activity and behavior. We will characterize the selectivity of sites isolated
from each electrode contact when different stimuli are held in working memory, and we will apply electrical
stimulation at either high (gamma) or low (beta) frequencies to disrupt or reinforce the memory of the stimulus.
Results from these experiments will inform strategies for effective remediation of working memory deficits in
patient populations.

Public health relevance
PROJECT NARRATIVE Many patients with neurological disorders and mental illnesses experience problems with thinking and memory. In this study we will determine how the brain keeps track of short-term memories, by recording activity from individual brain cells while patients perform memory tasks. This knowledge will help us to develop effective strategies to improve memory function.